Core 2: Biospecimen/Pathology Core

The overall goal of the Michigan Prostate SPORE Biospecimen/Pathology Core is to collect biological materials
with associated clinical information to facilitate translational prostate cancer research. The Core places patient
confidentiality and clinical care as a top priority. As a coordinated effort between pathology, urology, medical
oncology, radiation oncology, and Michigan Prostate SPORE researchers, the Core has developed a unified
informatics infrastructure that provides researchers a wide range of annotated samples. The specific goals of
the Core include: (1) Protection of patient welfare. The highest priority is given to assure that no research protocol
compromises pathology diagnosis or tumor staging. (2) Acquisition and processing of prostate tissues for
research. The Core assures that the widest range of prostate tissues and derived biomolecules are available
from various sources, including benign prostate tissue from patients without any known prostatic disease,
clinically localized prostate cancer, and metastatic castration-resistant prostate cancer (Michigan Legacy Tissue
Program). (3) High quality pathologic review of prostate tissues. Expert GU pathologists assure uniform review
of prostate tissue samples. (4) Pathology consultation for the purpose of designing translational research
projects. This service focuses on determining the types of tissues and amount required for the successful
completion of the research projects. (5) Quality assessment of prostate tissues and clinical data. The
Biospecimen/Pathology Core staff regularly evaluate frozen and formalin fixed tissues for adequacy. (6)
Development of technology appropriate for pathology-based translational research. These technologies include
novel targeted next-generation sequencing (NGS) methods to profile extracted RNA from post-digital rectal exam
urine, next-generation molecular profiling utilizing spatial transcriptomics (10X Genomics Visium), and novel
prostate cancer-focused targeted NGS assays available for profiling tissue-extracted DNA and RNA from
prostate cancer tumor specimens. (7) Provide support to ongoing clinical studies. The Core will continue to
provide tissue procurement services and/or high-quality pathology reviews of specimens from patients enrolled
in various clinical trials and studies. (8) Maintenance of clinical and pathology data with links to molecular studies.
The Core will continue to expand the detailed clinical and pathology database conforming to the NCI’s Common
Data Elements (CDE) guidelines, permitting queries between molecular findings and clinically relevant
outcomes. Michigan Prostate SPORE patient advocates will continue to provide their valuable input regarding
direction of the Biospecimen/Pathology Core. In summary, the Core will provide SPORE investigators with a
wealth of carefully annotated samples for translational research, while maintaining the highest level of clinical
care and patient confidentiality.